Risk and Resilience to Adolescent Substance Use: The Roles of Child Maltreatment and Youth Activity Space

PROJECT SUMMARY/ABSTRACT
Susan Yoon, PhD, MSW, is a social scientist whose overarching career goal is to prevent substance use and
improve health outcomes among vulnerable, at-risk youth by identifying key mechanisms for risk and resilience
to adolescent substance use following child maltreatment. This K01 Mentored Research Scientist Development
Award will provide Dr. Yoon with rigorous training and systematic mentored research experiences that will
accelerate her successful transition to an independent investigator in the field of adolescent substance use
research. A team of highly qualified and committed mentors, who are prominent researchers in their respective
fields, will guide and supervise her K01 research and training activities. The proposed career development plan
encompasses four hands-on training goals to improve her knowledge and skills in: 1) adolescent substance
use research with vulnerable youth; 2) the use of contextual/spatial (i.e., activity space) data; 3) the application
of the resilience framework; and 4) advanced statistics, including person-centered analysis, multi-level
modeling, and spatial analysis. During the K01 award period, Dr. Yoon will obtain and apply these new skills
and knowledge to address important questions about the complex associations among child maltreatment,
youth activity spaces—refers to areas or places a person visits in daily routine—and adolescent substance
use. Child maltreatment and adolescent substance use are two serious, tightly connected public health
concerns. Despite the well-established link between these phenomena, the underlying mechanisms and
moderators (protective factors) of this link remains elusive, significantly hampering our ability to effectively
prevent adolescent substance use. Thus, the proposed study aims to: 1) examine how distinct patterns of
longitudinal maltreatment experiences are associated with different patterns of adolescent substance use
trajectories; 2) investigate the mediating effects of risky attributes within youth's activity spaces on the
association between child maltreatment and adolescent substance use; and 3) determine the extent to which
protective attributes within youth's activity spaces buffers the impact of child maltreatment on substance use
during adolescence. To address the study aims, Dr. Yoon will employ creative integration and analysis of
diverse data sources, including data linkage between administrative child welfare records and geo-coded youth
spatial exposure data. The study also introduces theoretical innovation through the integration of resilience
theory and novel spatially-situated protective factors to understand resilience to substance use following child
maltreatment. This study directly addresses NIDA's research priorities and strategic goals of supporting
research to understand the complex interactions of environmental, behavioral, and social factors influencing
drug use trajectories. Findings will offer valuable insight into key contextual mechanisms and protective factors
that can be targeted in interventions to prevent substance use among high-risk, vulnerable youth.

Public health relevance
PROJECT NARRATIVE Child maltreatment and adolescent substance use are highly-prevalent and tightly-connected public health concerns in the United States. The current study aims to identify the pathways from child maltreatment to adolescent substance use by focusing on risky and protective attributes within youth activity spaces as critical underlying mechanisms. Findings from the proposed research will inform the development of more effective interventions to prevent substance use among high-risk youth by elucidating key contextual mechanisms and protective factors for adolescent substance use following child maltreatment.